Three-dimensional random access acousto-optical scanning two-photon microscope

Summary
This NIH grant proposal seeks funding to acquire a cutting-edge Femtonics Atlas
microscope at Baylor College of Medicine (BCM), with a specific focus on its
applications for neuroscience research. The Atlas will enable rapid, high-resolution
imaging of activity-dependent fluorescence in vitro and in vivo using calcium, voltage, or
neurotransmitter reporters. The Atlas combines two-photon excitation with acousto-
optical deflectors (AOD) scanning, allowing fast recordings of fluorescence from
arbitrary locations or shapes in a 3D volume without moving parts.
Over the past two decades, traditional two-photon laser-scanning microscopy (2PLSM)
has significantly advanced our understanding of neuronal function and structure due to
its ability to image activity deep in scattering tissue. However, standard 2PLSM is
limited by single-plane scanning, which is often not compatible with the geometry of
target structures such as dendrites or astrocytes. When combined with methods for fast
Z focusing, 2PLSM can scan multiple planes, but at the expense of reduced temporal
resolution. The Femtonics Atlas overcomes these limitations by rapidly pointing the
laser beam to any point within a 3D volume, enabling high-speed, random-access
imaging that is crucial for recording fast neuronal activity with the latest GCaMP8
calcium sensors and with genetically-encoded voltage indicators (GEVIs) like JEDI-2P
(developed at the St-Pierre lab here at BCM).
The proposal highlights the unique advantages of the Atlas to support a diverse set of
NIH-funded projects within the neuroscience department at BCM, with potential
applications in other departments as well. These projects will benefit enormously from
the ability to track activity in complex 3D structures of neurons and glia, to image
sparsely-labeled cells with high temporal resolution, and to deliver precise two-photon
optogenetic stimulation in parallel with imaging. With a group of nearly a dozen
enthusiastic neuroscientists looking forward to applying the Femtonics Atlas’s
capabilities to their research, bringing this microscope to Houston has the potential to
significantly advance our understanding of brain function and disease.

Public health relevance
Narrative This NIH grant proposal seeks funding to acquire a Femtonics Atlas microscope at Baylor College of Medicine (BCM) to enable rapid, high-resolution imaging of activity-dependent fluorescence in vitro and in vivo using calcium, voltage, or neurotransmitter reporters. The Atlas's advanced two-photon laser-scanning microscopy with acousto-optical deflectors allows for high-speed, random-access imaging of arbitrary locations in a 3D volume, overcoming the limitations of traditional single-plane scanning. This cutting-edge technology will significantly enhance various NIH-funded neuroscience projects at BCM by enabling precise tracking of neuronal and glial activity in complex 3D structures and delivering precise two-photon optogenetic stimulation.